Attending to all children: Examining the role of alpha oscillations in attention in young children with and without prenatal alcohol exposure (AsCENd)

Abstract
Attention deficits cause life-long challenges affecting academic and job performance, social relationships, and
life satisfaction. Attention problems typically begin at an early age and children with attention problems struggle
in school. Ideally, attention deficits would be identified before a child enters school. A primary limitation in the
field is our limited knowledge of the neural signatures of attention in young children. Children with prenatal
alcohol exposure (PAE) and children with a diagnosis of fetal alcohol spectrum disorder (FASD) related to PAE
experience persistent attention deficits, and PAE is present at birth. Therefore, studying children with and
without PAE provides us with an opportunity to examine neural signatures of attention at a young age in a
group of children at high risk of attention deficits. Children raised in lower socioeconomic households are also
at greater risk of attention problems, and due to high rates of poverty in New Mexico, we are well-positioned to
examine its role in attention in children with and without PAE. Research in adults indicates that alpha
oscillations play a key role in directing attention, but it is unknown how alpha oscillations are related to
attention early in development. Alpha oscillations are easily elicited during rest, modified during tasks, and
measurable across development. This study builds on (1) prior research demonstrating thalamus drives some
cortical alpha oscillations whereas others are driven by cortico-cortical connections or local network dynamics
and (2) studies in preclinical PAE models and research in children with PAE indicating disrupted cortico-
thalamic and cortico-cortical tracts with PAE. Aim 1 will establish the role of alpha oscillations and cortico-
thalamic or cortico-cortical connectivity in attention by measuring alpha oscillations during rest and task using
magnetoencephalography (MEG) and white matter integrity (WMI) using diffusion tensor imaging (DTI) in
typically developing children aged 4-7 years. Aim 2 will assess alterations in alpha oscillations and WMI and
their relation to attention deficits in children with PAE, relative to typically developing children. Aim 3 will
examine the developmental trajectory of alpha oscillations and WMI and their role in attention by following the
same children longitudinally until age seven. We hypothesize that alpha oscillations are directly related to WMI
and attention in typically developing children. Furthermore, alpha oscillations will be reduced in children with
PAE, and these reductions will be related to disruptions in WMI and attention deficits. We expect these effects
to be mediated by poverty in both typically developing children and children with PAE. We will test our
hypotheses by measuring alpha oscillations using MEG during 3 tasks that robustly manipulate alpha
oscillations in parietal cortex, somatomotor regions and the fronto-parietal network and examining how these
oscillations relate to WMI and attention. This study will provide foundational knowledge about the role of alpha
oscillations in attention in young children and may indicate potential biomarkers to improve early diagnosis and
intervention for FASD to inform our understanding of attention deficits broadly.

Public health relevance
Narrative This project will use state-of-the-art neuroimaging tools and behavioral assessments to understand the neural signatures of attention in young children with and without prenatal alcohol exposure. The long-term goal of the project is to identify a neurophysiological marker of attention deficits to facilitate early intervention for children with prenatal alcohol exposure (PAE) as well as children with attention deficits from other causes. This study addresses the needs of children with attention deficits and their families and the NIAAA Strategic Plan calling for early identification of PAE.